Phase behavior of proteins in crowded environments

PROJECT SUMMARY
Current research proposes protein phase separation as a key mechanism underlying the
formation of liquid-like biomolecular condensates, which play an integral role in numerous cellular
processes and age-related disorders. The interior of a living cell is a highly crowded environment,
therefore, to fully comprehend the phase behaviors and biological functions of proteins, it is critical
to consider the densely populated environment of cells, where proteins coexist with a wide variety
of molecules possessing diverse physical and chemical properties. To this end, researchers have
utilized various molecules as crowding agents to study protein phase behavior in this context.
While the effects of crowding on proteins have been studied to some extent, many open questions
remain to be addressed. The long-term goal of the proposed research is to unravel the
mechanism underlying the phase separation of proteins in living cells. Our previous research
explored the impact of two types of crowding agents on a model protein/polymer system, revealing
that they lead to distinct phase-separated complexes due to their different effects on individual
protein and polymer molecules. Therefore, based on the previous results, our central hypothesis
is that the observed macroscopic crowding phenomena are directly linked to how the crowding
agents affect the conformation and behavior of individual protein and polymer molecules at the
molecular level. The overall objectives of this study are to enhance our understanding of the
changes in conformation and intermolecular interactions that regulate protein phase behavior in
crowded environments, and how these changes impact the properties of the phase separated
proteins. The central hypothesis and objectives of this application will be tested and attained by
pursuing four specific aims: 1) investigate the effects of crowing on the phase transition of a
model protein/polymer system; 2) characterize the physical properties of the phase separated
protein/polymer complexes; 3) measure the conformation of individual protein and polymer
molecules in different crowding environments; 4) probe the effects of crowding on the protein-
protein and protein-polymer interactions. The proposed research is anticipated to have a
significant positive impact, as a detailed understanding on the protein phase behavior in
crowded environments will shed light on the formation, function, and fate of biomolecular
condensates. The contribution is significant because it marks the first step in a series of
investigations expected to lead to a comprehensive understanding of protein phase behavior in
crowded environments at the molecular level.

Public health relevance
PROJECT NARRATIVE This research investigates protein phase separation, a fundamental process underlying the formation of biomolecular condensates that are crucial for cellular functions and associated with age-related disorders. The study employs a model protein and polymer system as surrogates for proteins and nucleic acids, both are common precursors for biomolecular condensates. By examining the effects of a wide range of crowding agents commonly used to simulate the crowded environment within living cells, this study aims at elucidating the effects of crowding on the conformation and intermolecular interactions of protein and polymer molecules, and to establish connections between the molecular-level information and the bulk phase behavior of proteins. Collectively, our research will provide a comprehensive, molecular-level understanding of protein phase behavior in cell-like environments, thereby advancing the fields of biophysics and cellular biology, and opening new avenues for therapeutic development in diseases related to abnormal protein phase separation.